The Role of Alternative Splicing in FSHD Disease Models

Facioscapulohumeral muscular dystrophy (FSHD) is a prevalent form of muscular dystrophy caused by the
aberrant expression of the transcription factor DUX4, which leads to muscle toxicity and progressive
weakness. While previous research has identified transcriptional changes induced by DUX4, the mechanisms
through which DUX4 affects RNA processing, particularly alternative splicing, remain largely unexplored.
Alternative splicing is critical for muscle function, and its disruption may exacerbate muscle pathology in FSHD.
This project aims to investigate the role of DUX4 in regulating alternative splicing, with the goal of developing
an RNA splicing biomarker for FSHD.
The proposed research includes three specific aims. First, the project will characterize the interactions
between DUX4 and RNA in muscle cells to identify RNA targets of DUX4 that undergo alternative splicing (Aim
1). Second, the role of DUX4 in regulating the alternative splicing of TNNT1—a gene essential for muscle
contraction that is abnormally spliced in FSHD—will be explored, focusing on the potential cooperation
between DUX4 and splicing factors hnRNP U, DDX5, and FUS (Aim 2). Third, the project will develop an RNA
splicing biomarker for FSHD by identifying and validating splicing changes in patient-derived myotubes and
iPSC-derived myotubes (Aim 3).
To achieve these aims, the project will utilize advanced methodologies, including RNA-seq, CLIP-seq,
and splicing analysis tools such as DEXSeq. The research is expected to uncover molecular mechanisms
through which DUX4 disrupts splicing in FSHD, which may provide a foundation for future diagnostic and
therapeutic strategies. These findings will be crucial for developing clinical trials that assess splicing
biomarkers in FSHD patients.
This award will provide the applicant with the training and expertise in bioinformatics and RNA biology
necessary to become an independent investigator. Under the mentorship of experts in the field, the applicant
will gain proficiency in analyzing next-generation sequencing data and conducting complex RNA biology
assays. This project will establish a strong foundation for a research program focused on gene regulation in
muscular dystrophies and contribute to the development of targeted therapies for FSHD.

Public health relevance
Facioscapulohumeral muscular dystrophy (FSHD) is a debilitating genetic disorder that causes progressive muscle weakness. This research aims to develop an RNA splicing biomarker for FSHD, which could improve early diagnosis and help track the effectiveness of new treatments in clinical trials. By better understanding how the disease affects RNA processing, this study has the potential to advance the development of targeted therapies for FSHD patients.